Innate Lymphoid Cells and Tertiary Lymphoid Structures in Sarcoidosis

Enter the text here that is the new abstract information for your application.

Public health relevance
PROJECT NARRATIVE Sarcoidosis is a chronic inflammatory disorder that more commonly affects females (in a 2:1 female to male ratio) and causes severe fatigue, difficulty breathing, and pain in their joints and skin. Diagnostic tests and targeted clinical treatments remain major unmet clinical needs. We assess whether elevated levels of innate lymphoid cells in blood or tissue may be a diagnostic marker for sarcoidosis, and whether preventing B cell aggregation in granulomas represents a new targeted therapy for this devastating and understudied disease.